Diversity supplement to Analysis of Nonstationary Point Process Data

Project Summary Much mental health research uses neurophysiological measurements to describe the way neural activity within and across brain regions is related to behavioral function and dysfunction. One kind of signal, known as a spike train, comes from an individual neuron. Another, the local field potential (LFP), is based on activity from large numbers of neurons within specified parts of the brain. For both kinds of data, scientifically rigorous statistical analysis must accommodate unstable fluctuations, associated with movement or thought, known in statistics as non- stationarity. The continuing research program of this grant is to develop methods for analyzing non-stationary neural data. Of particular interest is the description of interactions among two or more brain areas. This application is for an administrative supplement to support an under-represented minority PhD student for two years. As documented by, among others, the National Science Foundation, people of African ancestry are severely under-represented in the sciences. The training provided to the candidate, under this supplement, would serve to elevate the candidate's research profile, and would ultimately contribute to enhancing diversity in the STEM workforce. The candidate's research concerns methods for identifying the flow of information from one brain area to another based on neural spike trains. Two major complications are, first, the noisiness of spike trains as conveyors of information and, second, the large numbers of neurons that must be considered simultaneously. Statistical methods developed very recently, through research supported by this grant, suggest very promising approaches to reducing the effects of noise and grappling with large networks of neurons. Based on these ideas, the candidate will develop a PhD thesis topic, and pursue it, with support from this supplement.

Public health relevance
Description of R01 and Candidate's Project Because neural network dysfunction is widely considered to be associated with psychopathology, new recording and stimulation technologies have the potential to greatly accelerate mental health research, thereby improving dramatically the treatments offered to patients. Still, although there have been many important advances in mental health research and treatment, in no case is any mental health disorder well understood mechanistically. Faced with the reality that each promising discovery inevitably reveals new subtleties, a reasonable experimental goal is to be able to change behavior in desirable ways by modifying specific brain circuits [5, 8] and, in animals, technologies exist for circuit disruptions that are precise in both space and time [4, 7]. However, determining the best location and time for such disruptions to occur, with minimal off-target effects, requires far greater knowledge of circuits than currently exist: we need good characterizations of interactions among brain areas, including their timing relative to behavior. The over- arching aim of our research is to provide statistical methods for describing the flow of information, based on evolving neural activity, among multiple areas of the brain during behavioral tasks. Neurophysiologists are starting to apply methods that can lead to breakthroughs, but the resulting data are complicated, and carefully-crafted statistical methods are needed. The research conducted under this grant over the past 18 years has helped lay the foundation for major advances through steady, systematic investigation of variability in neural signals and construction of new techniques. Our approach applies the knowledge accumulated in the discipline of statistics to the special circumstances of neurophysiology. The primary way neurons communicate is through rapid electrical discharges known as spikes, and se-quences of spikes are known as spike trains. A major focus of attention is the rate at which a neuron is ﬁring, and the way that rate varies with experimental conditions and behaviors. We and others have been trying to understand better the firing rate fluctuations among spike trains recorded simultaneously from many neurons, across multiple regions of the brain. Because each spike occurs over the course of roughly 1 mil-lisecond while behavior occurs over hundreds of milliseconds, it is reasonable to consider a spike train to be a stochastic sequence of isolated points in time which, in probability and statistics, is called a point process. Early theoretical research on point processes relied on an assumption of steady-state time-invariance, known as stationarity. Every behavioral setting, however, creates constantly-evolving neural activity. The origin of this grant in 2001 was our outline of a simple and tractable approach to neural spike train analysis that accommodates evolving, non-stationary activity. It has become a standard tool, and much of our research is based on similar point process statistical models except now, to describe complicated settings, they are much more elaborate. We also analyze and study local field potentials (LFPs), which result from all the neural currents gener-ated near the electrode (roughly within 150-200 microns), involving large numbers of neurons [3, 6]. The response of an LFP to varying conditions is less discriminative than individual neurons, but its power (vari-ability) can reveal situations in which a neural population is active, and it has been shown to correlate substantially with the BOLD fMRI signal [11, 12]. LFPs are especially useful for studying the role of oscillating neural circuits. Oscillations appear during many cognitive tasks, and changes in power and os-cillatory coupling have been associated with cognitive impairment [2, 10, 14]. Some of our research has been investigating the sources of LFPs in the cerebral cortex which, using biophysically-informed models, can be inferred to originate in particular cortical layers, thereby supplying important additional detail about dynamics and function [1, 9, 13]. Our Specific Aim 1 concerns (a) a new, putatively more accurate method of attributing LFPs to cortical sources, which allows us to explore cross-area interactions in greater detail than previously possible, (b) 1 simultaneous analysis of large numbers of LFPs, including those coming from two or more brain areas, and (c) identification of oscillatory interactions from multiple brain areas. Specific Aim 2 concerns (a) simulta-neous analysis of large numbers of spiking neurons, (b) identification of cross-correlation among brain areas based on large numbers of spiking neurons within each area, and (c) methods for analysis of precisely-timed synchronous (or nearly synchronous) spiking events, possibly in conjunction with oscillatory signals that are apparent in LFPs. Specific Aim 3 concerns (a) the combined assessment of interactions that occur at multiple timescales, (b) methods for relating large numbers of LFPs, which evolve across time, to behavior, and (c) creation of a simulation system based on realistic ground-truth models to test our methods. The candidate to be supported by the requested supplement, Tolani Olarinre, is now starting his third year in the joint Machine Learning and Statistics PhD program. We anticipate his finishing in 3 years, i.e., August 2024. Olarinre's research falls under our Specific Aim 2 (parts 2A and 2B), which concerns coordinated activity of spiking neurons across brain regions. When information appears to flow from one brain region to another, the time lag may be short, under 10 milliseconds. One way to track flow of information is to look for trial-to-trial variations, and see whether they tend to be consistent across regions. There are simple ways to try to do this, but it turns out they don't work: individual neural spike trains behave much like the simplest point processes, Poisson processes (they are different, but similar), with the consequence that the precise spike timing is unpredictable and, as a result, spike trains provide very noisy representations of evolving neural firing rates. One important component of our research has been to devise methods for reducing the effects of this Poisson-like noise. For example, if two brain regions are coordinated, when activity in one region occurs earlier than average, activity in the other region should tend to occur earlier than average. Olarinre has been working with another graduate student and, based on their work, we have documented the failure of simple methods for identifying this kind of information ﬂow. On the other hand, sophisticated statistical methods succeed in finding it. We expect to submit a manuscript for publication within the next few months. A major complexity involves the large numbers of neurons recorded within a region, and the possible in-teractions they may have among themselves. A now-standard way to identify such interactions, based on point process statistical modeling, is to put into the model “coupling” terms to measure the influence of one neuron on another. A former student, Neil Spencer, who recently defended his PhD under Kass's super-vision, has developed very interesting computationally-efficient methods for examining these interactions using network models. We have realized, however, that models with standard coupling terms suffer from the curse of Poisson-like noise. Thus, to be maximally effective they need to be modified. In outline we know what modifications to make, but devising a good algorithm and implementation will be challenging. This is a main part of the project Olarinre will next take up and, because novel method and implementation development of this kind requires a lot of time, it will most likely take him through 2022, so that during the Spring semester of 2023 he will be able to propose a thesis topic that includes network models and applies them to key problems. Spencer has acquired world-level expertise in cutting-edge Bayesian computation and he has agreed to collaborate with Olarinre by suggesting approaches, and modifications when the need arises, which will be very helpful. A letter from Dr. Spencer is provided with this application. In Olarinre's detailed work to date, he has found a wide diversity of neural responses within small regions of cortex. One of the problems he plans to investigate is the role of distinguishable subclasses of neurons. This would require, first, methods of defining these subclasses based on physiology (spiking patters), with consideration of anatomical location (cortical layer). Other key problems are to describe the role of thalamic 2 input, and the variability of network behavior across animals. The latter problem will require development of additional new, computationally-intensive methods. The methods Tolani develops should provide new insights into brain network activity. His thesis will likely include contributions to all of these problems, and will thereby yield far more specific descriptions than currently exist of the way neurons in a particular brain region interact in order to ”package” the information that gets communicated. Mentoring Experience of PI The PI, Kass, has extensive experience mentoring trainees. Within the Department of Statistics he served as graduate advisor before becoming Department Head, a position he held for 9 years. He was involved in a series of 4 NSF training grants (and was PI on 3), across 17 years, all of which had mentoring as a major component. In those capacities he created, supervised, and participated in both group and individual mentoring programs. Kass subsequently served for 3 years as Interim Head of the department-like structure now called the Neuroscience Institute at Carnegie Mellon (CMU), and was concurrently the interim CMU- side Co-Director of the Center for the Neural Basis of Cognition (CNBC), which is an umbrella organization run jointly by CMU and the University of Pittsburgh. In that role he supervised graduate training in the very large non-degree program (just under 150 students enrolled, steady-state), which supplements disciplinary PhD training as a certificated add-on. During Kass's time as Department Head in Statistics he visited Morehouse College in an attempt to find ways Carnegie Mellon could be helpful in supplementing the training of students from HBCUs. Out of that came a very successful summer program in basic statistics for those students interested in public health. From 2001 to 2007 we trained 33 students from 19 institutions. Many have gone on to very successful careers including advanced degrees, and we would like to think they were served well by being able to analyze and interpret data with confidence (one became President of the Eastern North America branch of the Biometric Society). Kass has also been PI of an NIH Blueprint for Neuroscience Research training grant in computational neuro- science, which is now commencing its 15th year. Our version of the NIH Blueprint training in computational neuroscience has had an important additional component, a 10-week summer program for undergraduates, typically rising seniors. The program is not aimed primarily at URMs, but we have tried to recruit them during a selective admissions process. Over the past 8 years we trained 18 URM students (just under 25% of the total). The training begins with 2 weeks of background lectures together with supervised computational labs, and this is followed by 8 weeks of research as a member of a faculty lab group. Our goal has been to give these students the kind of exciting and productive research experience that would encourage them to apply to graduate school in areas related to computational neuroscience, while also getting them better pre-pared to do so. The program has been run by a faculty member devoted to this project (for summer support); Kass has served not only as the PI of the program but also as an active participant, delivering lectures and supervising 1 or 2 undergraduate trainees himself each summer. Training and Career Development Plan Primary Mentoring Having gotten to know Olarinre over these past 2.5 years, Kass is aware of his unusual strengths and also the challenges he faces. Olarinre now has good training in graduate level statistics and machine learning. He also has an unusually strong background in software engineering (having worked at Intel for 5 years). There are, however, occasional holes in his background, and his progress is somewhat slower than many other students here (Carnegie Mellon attracts its share of the very top students in statistics and machine learning internationally). As a consequence, in addition to weekly group meetings that Kass 3 and Olarinre will attend, (i) Kass will meet with Olarinre, individually, at least once a week, and sometimes more often, (ii) Kass's review of Olarinre's progress will be continual (i.e., at least weekly), (iii) Kass will not assume Olarinre has absorbed aspects of research and professional development unless they have been assessed, and (iv) Kass and Olarinre will have frequent discussions about future publication plans, presentation plans, and PhD program milestone plans; from time to time they will also talk about career goals, and strategies for achieving them. Research Methods As we said, Olarinre's courses have provided him the foundational theory and meth-ods for statistical machine learning (he will be finished with coursework at the end of this semester). Be-coming an effective researcher in this area requires, in addition, (a) detailed understanding of results from the neuroscience literature, and their experimental contexts; ( b) appreciation of aspects of data collection, including pre-processing steps, that might affect analysis and conclusions; (c) strong cross-disciplinary com-munication skills; (d) an ability to collaborate with other analysts, ranging from postdoctoral researchers to undergraduates; (e) the knowledge and willingness to “break” statistical models in order to evaluate their applicability to the problem at hand; (f) a clear appreciation of what statistical models can and can not accomplish; and (g) the ability to envision a unified analytical evaluation built from many different compo-nents, and to develop a convincing explanatory description of the work. These elements of research methods provide a checklist for Kass in assessing Olarinre's progress. Assessment comes from probing discussions during individual meetings, as well as the written summaries of work that Kass will require before each weekly meeting (described below). Instruction for Olarinre will come from feedback, but will be reinforced by general comments—not directed at specific individuals—in group meetings. In addition, component skills in research methods are apparent in oral presentations, writing for publication, and writing to meet the requirements of PhD program milestones. Individual meetings with Kass Olarinre will present his work in a structured form. Prior to each meeting, Olarinre will send to Kass a short document that contains key figures and equations, together with very concise explanations and conclusions; it will also include any concerns and queries he might have, and his thoughts on next steps, mainly for the following week. All points of summary and interpretation will have to be presented as whole-sentence bullet points, and all figures must have detailed captions to make them largely self-contained. Kass has found the whole-sentence bullet points, especially, to be an extremely useful device for trainees: it forces them to articulate a series of ideas that express, conceptually, their key findings and observations. This special format has challenged Olarinre, as it does many students—it's easy to avoid following the format when rushed, but the benefits are improved communication, together with development of a skill that will serve him well for future oral and written presentations. By including next steps, in writing, he will habituate his planning process. As he reviews the previous week's plans together with their current week's results, Olarinre will gain confidence in his progress. Furthermore, such documents can grow relatively easily into manuscripts. Kass emphasizes the importance of writing, and will guide Olarinre toward clarifying the structure and style of his written work, in conjunction with improving its substance. Mentoring topics and timeline In addition to the specifics of research, and its presentation, the mentoring that Kass will provide to Olarinre will include multiple topics. We have structured these again in a kind of check-list format (like the multiple aspects of research methods) and, in addition, have laid out a detailed timeline for them, in tabular form. The topics are explained briefly, following the table itself. Program milestones: These include finishing, presenting, and writing up an Advanced Data Analysis project in Fall 2021, the thesis proposal, in the summer of 2023; and the thesis defense in the summer of 2024. The Advanced Data Analysis project must involve a major cross-disciplinary effort (at least 12 months) and Olarinre must have an external co-advisor in addition to Kass. Olarinre's research has been done in collaboration with Dr. Joshua Siegle at the Allen Brain Institute. Dr. Siegle provided a letter of collaboration for the most recent grant application submission, and he will serve as formal co-advisor. Pub-lications: We anticipate 3 publications from the thesis, with the first being based on the Advanced Data Analysis project; initial work on the first paper will begin by the end of this summer, after which Olarinre will focus entirely on finishing the research and presenting it, with the paper being completed and submitted during Spring 2022. Work on the second paper will occur in conjunction with the thesis proposal in Spring 2023, while the third paper will be written in time for its incorporation into the thesis itself, in Spring 2024. Meetings: Olarinre will attend and present results at multiple meetings, including the 2022 international meeting on Statistical Analysis of Neural Data (SAND10), the 2023 meeting on computational and systems neuroscience (COSYNE), and the 2023 Joint Statistical Meeting. This latter is the largest statistical meeting in the world, and one of the best opportunities for networking. At all of these meetings Kass will make sure Olarinre is “plugged in,” by introducing him to researchers at different levels of seniority who share his interests. In 2024 Olarinre will attend at least one additional meeting, possibly the annual meeting of the biometric society (ENAR) during the Spring. Teaching: Large undergraduate enrollments at institutions like CMU have made teaching assistants essential to delivery of most courses offered by departments like Statistics & Data Science. Since our first NSF training grant in 1996, Kass has recognized a much broader importance of TAing and related experiences to the development of graduate students in statistics. One of the pillars in our understanding is the recognition that much the same skills are used when teaching as when communicating technical material to less technical collaborators. Thus, regardless of Olarinre's ultimate career path, he will be served well by understanding what makes teachers effective, and by guided practice. Olarinre will serve as TA during Fall 2022 and Fall 2023. (While he is TAing, Olarinre will not be supported by this supplement.) Because he is in the joint PhD program with Machine Learning, he is expected to serve as a TA for one of their courses and one of the courses offered by Statistics & Data Science. We are very fortunate to have here at CMU a leading center for teaching, the Eberly Center for Teaching Excellence, the director of which, who holds a PhD in cognitive psychology, Kass collaborated with extensively early in her career. The center is a national leader in the formulation of good practices for undergraduate teaching and is unusual in its explicit use, in its many programs and materials, of high-quality research in educational psychology. The Eberly Center offers a series of workshops for graduate students, which Olarinre will at-tend. Writing Skills: In addition to what we have already said, the timeline indicates when attention will be focused on document production. Presentation Skills: This is continual, through group presentations. Kass will review slides and provide feedback during practice sessions for all milestones and professional meeting presentations. Grant writing: Kass will go over with the NeuroStats group the process of grant writing, and with Olarinre individually as preparation for his thesis proposal and for his postdoctoral job search. On these occasions Olarinre will produce a short mock grant proposal, including specific aims, that Kass and others will critique. Reviewing: Kass is frequently asked to review articles for publication in leading journals and almost always asks a trainee to serve as a co-reviewer. Olarinre will get the chance to review such articles on at least two occasions, planned for summer of 2022 and 2023, as those are times with minimal additional responsibilities for him. Kass will guide him through the process. This is also a general topic that comes up in our NeuroStats research group, so discussions there (with several faculty) will reinforce best practices. Time management: Kass will review with Olarinre his strategies and tactics for time management, especially when key deadlines are looming. Ethics: Kass will discuss ethical issues with Olarinre as they arise naturally during the interdisciplinary collaboration and publication process. In addition, formal sessions will occur in the NeuroStats group. Topics Kass plans to discuss, and has discussed with other groups previously, include individual responsibilities when working together as a team across se-niority levels; determining authorship; plagiarism and acknowledgment of previous work; responsibility to publish; redundancy or duplication of publications; integrity in reporting statistical results; careful attention to statistical assumptions; making data and code available; intellectual property involving novel methodol-ogy; accuracy, acknowledgment of previous results, and responsibility to educate during oral presentations; confidentiality and impartiality in reviewing the work of others; honest representation of work, accuracy of budgets, and responsible use of funds in grant proposals; types of scientific misconduct; complexity of typ-ical scenarios; responsibility and appropriate channels for reporting. Sessions are planned for each Spring, 2022, 2023, and 2024. Job hunting: Kass will ask several former trainees to discuss with the NeuroStats group their experiences, including types of jobs, interview preparation, honest representation of self, and the problem of assessing the multiple trade-offs among alternatives. These sessions are planned for each Fall, 2021, 2022, 2023. Kass will of course also discuss all of these topics with Olarinre when it is time for him to begin his search for his next position, presumably as a postdoctoral fellow. Additional Mentoring by Dr. Emery Brown Olarinre will be mentored primarily by Kass, with some supplementary mentoring by Dr. Emery Brown, at MIT. Brown has had a long-term collaboration with Kass (they wrote two highly-cited review papers on statistics in neurophysiology as well as an influential paper on graduate training in statistics). Brown is unusually accomplished: he is an MD-PhD, the only person to hold endowed chairs at both MIT and Harvard Medical School, a member of all 3 National Academies, and he is the 2020 winner of the Swartz Prize in Computational Neuroscience from the Society for Neu-roscience. Brown is deeply interested in the research topics Olarinre is pursuing and he is also himself an unusually successful mentor, including of trainees from under-represented groups. Dr. Brown, who is African-American, has also been very involved in diversity efforts at MIT and Harvard Medical School. The additional wisdom and advice Dr. Brown can offer Olarinre will be invaluable. A letter of collaboration for this special purpose is supplied with our application. Specifically, Brown has agreed to listen to Olarinre give a formal presentation, give him feedback, and discuss with him his goals and progress toward them. This will occur in Spring 2022, before Olarinre gives his first presentation at the SAND10 meeting, and again in Summer 2023 in preparation for Olarinre's attendance and presentation at the Joint Statistical Meeting. At that time Brown will also talk to Olarinre about job search, which will be commencing. 6